AI-Powered chemical-pathway-patient-directed polypharmacology for OUD therapy

Abstract
Opioid Use Disorder (OUD) presents substantial health and societal challenges, particularly in the US. The
proposal aims to discover novel small molecule therapeutics for safe and effective treatment of OUD. We will
identify multi-cell type and multi-target polypharmacological compounds, focusing on opioid oxycodone in the
Phase I. Recent studies highlight that not only neurons but also glial cells are involved in opioid addiction,
affecting communication and neuronal plasticity. Furthermore, OUD impacts both the central nervous system
and peripheral immune systems, with different opioids affecting various cell types distinctly. Thus, effective OUD
treatment requires modulating multiple cell types and drug targets to restore brain function. Traditional drug
discovery approaches are insufficient for OUD due to the complexity of the disease and the lack of specific drug
targets and high-throughput phenotype readouts. Moreover, there are limited methods to understand OUD's
complexity for polypharmacological lead discovery. This proposal seeks to overcome these challenges by
leveraging Artificial Intelligence (AI) to develop a novel drug discovery strategy that integrates target-based and
phenotype-based methodologies, aiming to identify new drug candidates for OUD efficiently. Specifically, we will
develop the AI platform µ3.ai and apply it to OUD drug discovery. This platform will generate multi-cell type, multi-
objective, multi-target lead compounds to restore OUD patient omics profiles to a non-addictive state. µ3.ai
combines four AI models that 1) predicts dose-dependent chemical-induced cell viability and transcriptomics for
phenotype-based drug discovery, 2) provides accurate genome-scale binding affinity predictions, 3) searches
for molecules with desired efficacy and safety profiles, and 4) prioritizes cell type-specific OUD targets.
Additionally, we will develop a human-in-the-loop active learning strategy. This approach involves close
collaboration between medicinal chemists and AI scientists to iteratively refine µ3.ai and discover new
polypharmacological therapeutics. This strategy utilizes Reinforcement Learning from Human Feedback (RLHF)
to enhance the AI platform. It seamlessly integrates AI-powered molecular generation, property predictions,
organic synthesis, in vitro assays, and compound testing in cell line models. In Phase I, established on the solid
evidences from patient-derived single cell RNA-seq studies, we will target oxycodone dysregulates type I
interferon signaling in neurons and astrocytes. Our goal is to restore the expression of multiple dysregulated
genes (STAT1, ISG15, BST2, IFI44L, IFITM3, IFI27, PARP14, PLSCR1, B2M, P2RY14, etc.) in the type I
interferon signaling to their normal state. The successful conclusion of this study will establish a robust
groundwork for the exploration of OUD drug development endeavors in Phase II, thereby making substantial
progress towards the objectives of the HEAL initiative of the National Institutes of Health (NIH).

Public health relevance
Relevance Statement The unmet need in the treatment of Opioid Use Disorders (OUD) poses a great threat to human health and welfare. The conventional drug discovery process has yielded very few successes. New approaches are needed to reduce the time and cost in drug discovery and development. We propose a novel artificial intelligence powered polypharmacology approach to accelerate OUD drug discovery and development.